Impact of inflammatory lipids on Yersinia pestis infection

ABSTRACT
Yersinia pestis causes the acute human disease commonly referred to as plague. A hallmark manifestation of
this disease is delayed inflammation despite active bacterial replication. Y. pestis modulates inflammation by
actively inhibiting the expression of pro-inflammatory cytokines via the action of a group of proteins called Yop
effectors that are directly injected into host cells by a bacterial type three secretion system (T3SS). Because
establishment of this non-inflammatory environment is key for Y. pestis to colonize the host, understanding how
Y. pestis modulates the host inflammatory response during early stages of infection will provide crucial insights
into both the pathogenesis of the bacterium and potential strategies to improve therapy. Lipid mediators, such
as members of the eicosanoid family, are essential to initiate the cascade of signaling events that regulates
inflammation. Therefore, disruption of the synthesis of pro-inflammatory eicosanoids can effectively stifle a rapid
immune response. Despite their importance in initiating inflammation, the role of lipid mediators in the context of
plague has not been previously investigated. Recently, we discovered a dysregulation in eicosanoid synthesis
during pneumonic plague, highlighted by the inhibition in the synthesis of the pro-inflammatory lipid leukotriene
B4 (LTB4). Furthermore, using Y. pestis mutants we uncovered a novel mechanism for the recognition of the
T3SS by neutrophils that triggers LTB4 synthesis, which is normally inhibited by the Yop effectors. Together,
these discoveries support a conceptually innovative hypothesis that Y. pestis actively manipulates the synthesis
of lipid mediators to disrupt the proper inflammatory cascade that would normally recruit circulating leukocytes
to control infection. In Aim 1, we will test this hypothesis using animal models to define the contribution of
eicosanoids to the host response during plague and determine how disruption of LTB4 synthesis benefits Y.
pestis. In Aim 2, we will use Y. pestis as a tool to define the molecular mechanisms responsible for T3SS-
dependent LTB4 synthesis by neutrophils. Because lipid mediators of inflammation have been overlooked in the
context of Y. pestis immune evasion, completion of these studies will significantly transform our conceptual
understanding of the early immune events during pneumonic plague.

Public health relevance
PROJECT NARRATIVE Inflammation is controlled by a cascade of signaling events which are initiated by the secretion of lipid mediators by leukocytes to recruit and activate additional immune cells to sites of infection. Our goal is to define how Y. pestis dysregulation of host lipid mediator synthesis contributes to the establishment of plague. Because the inhibition of inflammation is key to Y. pestis virulence, defining the role of host lipid mediators during plague is essential for us to understand the pathogenesis of this bacterium and provide new insights to improve current plague therapy.